Investigating Environmental Risk Factors for Breast Cancer Using Adductomics

PROJECT SUMMARY/ABSTRACT
Despite years of research, few modifiable risk factors for breast cancer have been identified and the incidence
of breast cancer remains high with over 260,000 new cases estimated to arise this year. Established risk
factors, such as a woman's reproductive history, body size, smoking, and alcohol intake, are estimated to
explain only about half of breast cancer cases. In addition, the underlying biological mechanisms linking
environmental risk factors and breast cancer are complex and are not well understood. As a result, new
approaches are required that can help identify environmental causes of breast cancer.
In this proposal, we apply a novel biomarker approach using protein adduct profiles (i.e., adductomics) to
investigate associations between environmental exposures and breast cancer risk in the Sister Study. Because
the Sister Study is a nationwide prospective cohort that was specifically designed to investigate environmental
risk factors for breast cancer, it is an ideal cohort to investigate the hypotheses outlined in this proposal. We
will focus specifically on Cys34 adducts of human serum albumin (HSA-Cys34), which is a nuecleophilic
“hotspot” on HSA that scavenges reactive electrophiles from circulating blood arising from both exogenous and
endogenous sources. We will first use an untargeted adductomics approach in our discovery experiments
using high-resolution mass spectrometry to identify new adduct features. We will then employ a
complementary targeted adductomics approach with enhanced analytical sensitivity and higher sample
throughput to measure adduct profiles in stored plasma samples collected at baseline from 1,800 incident
breast cancer cases and a random sample of 1,800 Sister Study participants. Adducts will be compared across
groups to identify discordant adducts, and we will use time-to-diagnosis in our regression models to help
differentiate between causal and responsive breast cancer biomarkers. Analyses will also be performed to
investigate associations specificto breast cancer subtypes defined by ER/PR and HER2 status.Finally, we will
perform secondary analyses and investigate associations between HSA-Cys34 adducts and environmental
exposures using existing air pollution exposure data. To achieve our study goals, we will integrate
methodological and conceptual tools from the fields of exposure science, cancer epidemiology, and cancer
biology to forge a transdisciplinary approach for investigating environmental risk factors for breast cancer. This
project has the potential for high impact by potentially identifying modifiable risk factors for breast cancer, and
identifying underlying biological pathways linking the environment and breast cancer etiology.

Public health relevance
PROJECT NARRATIVE In this proposal, we will apply adductomics to investigate environmental risk factors for breast cancer in the Sister Study cohort. Adduct profiles will be quantified in plasma from 1,800 incident breast cancer cases and a random sample of 1,800 Sister Study participants. We will also perform secondary analyses to investigate associations between adducts and environmental exposures.